Optimizing Neuromodulation Therapies for Epilepsy: Identifying the Right Patient, Right Place, and Right Time for Stimulation

PROJECT SUMMARY
Responsive neurostimulation (RNS) is used as a treatment for epilepsy that does not respond to medication.
However, its effectiveness varies significantly from one patient to another. While it can render some patients
almost completely seizure-free, others see no improvement. Additionally, some patients may take years to
achieve a reasonable benefit. This project aims to identify factors that determine a patient’s response to RNS,
focusing on three specific objectives.
Aim 1: Connectivity
This aim will utilize patient-specific white-matter connectivity, structural imaging, and stimulation field modeling
to identify networks crucial for positive RNS outcomes.
Aim 2: Stimulation Timing
Given that neuroplasticity likely underpins the gradually improving efficacy of RNS but is hindered during
periods of frequent epileptiform activity, this aim will investigate whether periods free from prolonged
epileptiform episodes (states with a low risk of seizures) correlate with better long-term RNS outcomes. It will
also assess whether delivering stimulation during these low-risk states enhances RNS effectiveness.
Aim 3: Background Rhythms
This aim will explore circadian fluctuations in background neural activity as a potential predictor of patient
response to RNS.
Successfully achieving these aims will not only enhance our understanding of neuromodulation in epilepsy but
also inspire new trials of innovative closed-loop stimulation algorithms, network-based targeting
methodologies, and prognostic tools. In the future, these advancements set a foundation for improving
neuromodulation outcomes, accelerating how quickly worthwhile benefits are achieved, and sparing patients
unnecessary and ineffective surgeries.

Public health relevance
PROJECT NARRATIVE Medication-resistant epilepsy is sometimes treated with implanted devices that electrically stimulate the brain. These devices take years to work in some cases and fail to work at all in many others. We propose identifying factors driving this variability by (1) identifying specific brain circuits that need to be stimulated for optimal outcomes, (2) finding the best timing for delivering stimulation to reduce seizures, and (3) using daily fluctuations in brain activity to predict which patients will respond to stimulation.